P30-Core Grant for Vision Research

Overall Summary
Continued support is requested for the NEI Core Grant for Vision Research that supports investigators of the
Atlanta Vision Research Community (AVRC). This Center Grant renewal application includes three
Resource/Service Cores: (1) Structural Biology and Imaging, (2) Functional Genomics and Proteomics, and (3)
Bioinformatics and Biostatistics. The AVRC Core grant supports collaborative vision research and service
among 23 faculty with 18 eligible NEI funded R01s, 24 postdoctoral fellows, and 38 predoctoral fellows. This
support comes largely via the expertise and service of AVRC personnel, their training of AVRC faculty and staff,
and the availability of equipment, supplies, and other resources. In the past 5 years, the Core grant contributed
to the generation of 193 peer-reviewed publications and to many new and competing renewal NEI-funded
R01s. During the next 5 years, we are actively recruiting 5-7 junior research tenure-track faculty who will re-
invigorate the AVRC and the EEC, increasing the need, value, and scientific impact of this P30 Core grant.
The Structural Biology and Imaging (SBI) Core provides resources and services for members of the AVRC with
regard to determining the relationship between normal and abnormal structure of ocular structures in healthy
tissue and in disease models with and without experimental therapies. Support is provided for structure-
function studies with an emphasis on retinal function, retinal degeneration/injury, RPE morphometry, ocular
oncology and gene/drug delivery. The Core supports ultrasonography, immunohistochemistry, confocal
microscopy, fluorescence image analysis, and light and electron microscopy services.
The goal of the Functional Genomics and Proteomics (FG&P) Core is to enhance research that increases our
understanding of how biological function (e.g., vision) arises from the information encoded in an organism's
genome and is modified by epigenetics. The Core supports molecular, biochemical, and phenotypic
experiments via six sections: DNA/RNA services, protein/small molecule analysis, cell culture, and
ocular/vision structural and functional analysis, rodent ocular microsurgery, and mouse colony services.
Approaches include scanning laser ophthalmoscopy, SD-OCT, fundus imaging, precision micrometry,
photorefraction, rebound tonometry, ERG, OKT, HPLC, LC-MS, PCR, LCM, immunoblotting and ELISA, flow-
cytometry, protein sequencing, microarray analysis, and NexGen sequencing.
The Bioinformatics and Biostatistics (Bioanalysis) Core provides biostatistics, bioinformatics, data management,
electronic notebooks, data backups, and advanced computational analyses. The support includes effort of
Core-dedicated informaticists and statisticians, advanced software, and cloud-computing access.
An Advisory Committee aids the Core directors to insure full and equitable use of the facilities and to advise on
creation of new resources based on need or elimination of components that are underutilized. The Cores have
increased and will continue to increase research productivity by providing common services to stimulate and
facilitate collaborative studies among faculty and to attract other academic disciplines to vision research.

Public health relevance
Project Narrative The AVRC P30 Core facility serves as a centralized vision research resource in Atlanta where faculty from Emory University, Georgia Institute of Technology, Georgia State University, Morehouse School of Medicine, and The Atlanta Veterans Administration Medical Center can undertake joint studies in vision research. The P30 Core facilitates the research of investigators holding NEI R01 grants by providing access to equipment and services that would not be possible on individual R01 grants. The P30 Core also promotes the research projects of pre- and postdoctoral fellows supported by our NEI Training Grant (T32 EY007092-34), recently renewed for five years (2020-2025) and buttresses active recruitment of new tenure-track research faculty.